Dissecting neural circuits for mechanical itch

Chronic itch is a severe clinical problem that afflicts a large number of humans and it is very difficult to treat.
Understanding the chronic itch circuitry and molecular mechanisms is critical to developing new therapies for
this intractable disease. Mechanical itch sensitization (alloknesis) is one common symptom in many of chronic
itch patients. Our previous work has identified neuropeptide Y-positive (NPY+) spinal inhibitory interneurons that
gates mechanical itch. Our findings raise two fundamental questions: 1) What are the specific excitatory neurons
in the dorsal spinal cord that transmit mechanical itch? 2) Does dysregulation of this pathway lead to chronic
itch? Recently we have identified that spinal excitatory interneurons expressing Urocortin 3::Cre (Ucn3+) are
mechanical itch-transmission neurons, which do not transmit touch, pain and chemical itch. Retrograde rabies
virus tracing showed that NPY+ neurons monosynaptically connect to Ucn3+ neurons in the dorsal spinal cord.
The goal of this project is to elucidate the spinal circuits that transmit and gate mechanical itch, and to study how
the circuits are altered in chronic itch conditions.
Aim 1: Delineate the functional organization of the spinal microcircuit that processes mechanical itch. We will
examine the functional connections from NPY+ neurons onto Ucn3+ neurons. We will map the sensory inputs
from dorsal root ganglion (DRG) neurons onto Ucn3+ and NPY+ neurons.
Aim 2: Determine the mechanisms of mechanical itch sensitization in chronic itch conditions. We will test the
mechanical itch sensitization and spontaneous itch behaviors in various chronic itch conditions after ablating
spinal Ucn3+ interneurons. We will characterize the electrical properties of Ucn3+ and NPY+ neurons and
synaptic transmission in the spinal mechanical itch circuits in chronic itch conditions. We will investigate whether
disinhibition of spinal mechanical itch circuits is a common mechanism of mechanical itch sensitization in various
chronic itch conditions. Finally, we will determine the disinhibition mechanisms in chronic itch.

Public health relevance
Chronic itch patients often experience associated mechanical itch sensitization. Our studies suggest peripheral Aβ mechanoreceptors, together with spinal Ucn3+ excitatory and NPY+ inhibitory neurons, form a microcircuit that transmits and gates mechanical itch. Therefore, functional analysis of the organization of this circuit and determine how it is altered under chronic itch conditions, will not only provide a mechanistic insight to chronic itch but also lead to develop novel itch therapeutics.